The placental epitranscriptome as a novel mechanism behind prenatal metal mixture exposures and child growth and development

PROJECT SUMMARY
Maternal exposure to complex metal mixtures during pregnancy may impair child growth and development to
impact later health. In New York City (NYC), pregnant individuals from low-income and Hispanic communities
are at risk of toxic metals exposure and children from these communities are also more likely to be born small-
for-gestational age (SGA) or with low birthweight, dictating later child growth trajectories, educational attainment,
and socioeconomic advancement. The placenta is the master regulator of fetal development and a first line of
defense against toxic metal exposures. Direct and indirect interactions between toxic (e.g., arsenic [As],
cadmium [Cd], lead [Pb]) and essential (e.g., manganese [Mn], selenium [Se], zinc [Zn]) metals in placental
tissue may result in cellular and molecular damage that can impact placental function. Defining concrete
mechanism(s) for the effects of metals on the placenta will advance efforts to protect millions of children from a
widespread threat. Yet, our insight into placental mechanisms linking prenatal metal exposures to impaired
growth is limited. The discovery of post-transcriptional modifications of RNA, collectively named the
epitranscriptome, as key regulators of placental gene expression provide an innovative avenue to address this
gap. N6-methyladenosine (m6A) is the most prevalent epitranscriptomic modification on messenger RNA (mRNA)
and modulates mRNA splicing, stability, and translation. m6A and its reader, writer, and eraser proteins (RWEs)
that interpret, add, and remove m6A marks, are responsive to toxicant exposures and regulate the cellular
response to oxidative stress and inflammation, which are key processes governing metal toxicity to the placenta.
These changes in m6A can subsequently regulate downstream proteomic responses to toxicant exposure. We
hypothesize that essential (Mn, Se, Zn, etc.) and toxic (As, Cd, Pb, etc.) metals accumulated in the placenta
directly influence child health in utero by dysregulating the m6A epitranscriptome and downstream proteome. We
will test our hypotheses with a discovery-replication design in two NYC-based, low income, Hispanic birth
cohorts, Fair Start (FS) (N=400) and Sibling-Hermanos (Hermanos) (N=100). In Aim 1, we will use placental
tissue to investigate 19 metals and their associations with expression of 18 m6A RWEs, transcript-level m6A from
m6A-sequencing, and the inflammation and metabolism-related proteome. In Aim 2, we will identify placental
m6A epitranscriptome and proteome alterations associated with birth outcomes (SGA, birthweight, gestational
length, head circumference, ponderal index) and early child growth trajectories (height, weight, BMI) at ages 0.5,
1, 2, 3, 5, 7, and 9 years. In Aim 3, we will construct a placental “metallome” – a network of the m6A
epitranscriptome and proteome linking prenatal metals to birth outcomes and child growth trajectories. Together,
these aims will lead to novel insight into the mechanisms linking placental metals, the placental epitranscriptome,
and the ensuing effects on child growth and development. It will open new avenues for metals risk assessment
and the development of placenta-based therapeutics to avert the harmful impacts of metals on child health.

Public health relevance
PROJECT NARRATIVE Prenatal metal exposures are consistently linked with altered child growth and development, and placental dysfunction is central to these effects. We propose the first study on the impact of metals on the placenta N6- methyladenosine (m6A) epitranscriptome, the ensuing effects on the placental proteome, and child birth outcomes and growth trajectories. Our focus on the placenta—an extraembryonic tissue that is key to early-life programming—will lead to novel insight into the mechanisms governing the effects of prenatal metal exposure and may uncover new molecular targets and biomarkers for treatment and prevention.